Analyzing brain-wide bases of neuroplastic change using new imaging tools

The mammalian brain is constantly being shaped by input from the body and external world. The brain's plasticity
involves changes in gene expression, protein synthesis and activity, synaptic function, and neuronal growth and
death. Understanding how these processes are influenced by stimuli, and how they in turn mold profiles of neural
activity and behavior, requires an ability to map the dynamics of molecular and cellular-level changes as they
occur throughout the life of an individual. We recently developed an imaging method that enables bioluminescent
reporter proteins to be monitored throughout the living brain using hemodynamic magnetic resonance imaging
(MRI). Our method, called BLUsH, provides noninvasive readouts of reporter expression at submillimeter
resolution in individual animals over time intervals ranging from minutes to days, or longer. In initial studies, we
have shown that BLUsH can be used to delineate viral tracing patterns and expression of activity-dependent
immediate early genes (IEGs) in vivo. These and related approaches permit longitudinal studies of brain-
behavior associations that were previously extremely difficult to study. In this project, we will apply BLUsH to
address several paradigmatic questions about brain-wide plasticity: (1) What are the spatiotemporal relationships
between neural activity and plasticity gene induction? (2) How are experience-dependent changes in the physical
structure of the brain driven by molecular and cellular processes? (3) How does repeated exposure to a stimulus
or behavior affect characteristics of plasticity phenomena throughout the brain? (4) What features of
neuroplasticity are predictive of individual behavioral variability?
We will approach these questions through three specific aims: In Aim 1, we will apply BLUsH IEG imaging
and conventional functional MRI (fMRI) in animal models of opioid use disorder to measure relationships
between neural activity and plasticity gene induction. We will test hypotheses about variation of these processes
over experience and among brain regions and individual animals, in experiments that we expect to reflect broadly
on the use and interpretation of IEG mapping in neuroscience. In Aim 2, we will evaluate the contribution of
neurogenesis and astrocytic remodeling to neuroanatomical change in a mouse model of voluntary exercise. We
will assess whether molecular and cellular markers of neuroplasticity predict individual behavioral performance
and test hypotheses about involvement of specific brain structures. In Aim 3, we will improve characteristics of
the BLUsH system itself, aiming to enable applications of BLUsH in nontransgenic animals and using multiplexed
reporters. The new strategies will be validated in the experimental paradigms of Aim 1, and will ultimately enable
applications of BLUsH to studies of plasticity and other phenomena in diverse animal models.

Public health relevance
The mammalian brain is constantly being shaped by input from the body and external world. This project will use new noninvasive imaging techniques to measure molecular and cellular processes that change the brain during ongoing behavioral experience. This work will help explain the origins of individual differences and the connec- tions between behavior and neurobiological changes over time, while also producing experimental tools of broad utility in neuroscience.